Muscle stem cell therapy for volumetric muscle loss

Major trauma can cause volumetric muscle loss (VML) resulting in life-long disability. Although skeletal
muscle is capable of remarkable regenerative potential, when injury is massive and destroys the underlying
architecture, regeneration is aborted and is characterized instead by scar tissue formation. The standard of
care in such injuries is wound closure, leaving little hope for functional recovery. The promise of regenerative
medicine is the full regeneration of damaged tissues, either by promoting repair from endogenous stem cells or
by the transplantation of cells to enhance regeneration. Perhaps the best example of this is skin grafting in the
setting of massive tissue loss in burn victims. The fact that grafted skin contains endogenous stem cells
assures that the graft will not only restore function acutely but also chronically as the stem cells function to
replenish skin cells that are lost during the normal turnover of the tissue. Likewise, the long-term goal of
regenerative medicine is to be able to restore damaged tissue and maintain that tissue for the full lifetime of the
individual.
Major advances have been made in the culture and transplantation of muscle stem cells (MuSCs, also
known as “satellite cells”) in recent decades, primarily in rodent models of muscle injury and degenerative
disease. It has been known for over 40 years that transplanted myoblasts, the more differentiated progeny of
MuSCs, can contribute to new muscle formation in the host. However, it has long been recognized that those
cells have limited regenerative capacity and fail to form new stem cells. In our ongoing studies, supported by
extensive Preliminary Data, we have been able to generate “bioconstructs” that consist of decellularized
muscle scaffolds into which we have engrafted MuSCs in a hydrogel. When this whole bioconstruct is
transplanted into a VML lesion in a mouse hindlimb muscle, we are currently able to achieve limited structural
and functional restoration. The major focus of the studies of this proposal is the development of this technology
so as to optimize MuSC treatment of VML lesions and to design a scalable therapy that could be translated to
humans. Toward this goal, we have outlined three Specific Aims, each based on extensive Preliminary Data: 1)
To enhance MuSC therapy by generative bioconstructs that contain other cellular components of the MuSC
niche so as to improve the engraftment and de novo muscle fiber formation by the MuSCs; 2) To optimize the
use of physical activity in the form of voluntary running or forced treadmill running to enhance the efficacy of
MuSC treatment of VML lesions; and 3) To assess our ability to scale up our model using at 10-fold increase in
VML size and treatment with two separate approaches – a direct scaling of our bioconstruct and the use of
“modular” bioconstructs.
The overall goal of this proposal is to develop a scalable technology using MuSC bioconstruct
transplantation for the treatment of VML. This will have direct and immediate relevance to Veterans who are
suffering from skeletal muscle injuries, injuries that have limited their functional capacity and that, to date, have
had no hope of further recovery. Our goal is to develop a novel therapeutic approach to muscle tissue repair
based upon a deep understanding of the basic stem cell biology, a state-of-the-art application of
bioengineering approaches to these clinical challenges, and a firm commitment to the clinical/translational
mission to improve the health and quality of life of Veterans whose function and further rehabilitation is limited
by the lack of effective therapeutic options.

Public health relevance
The major focus of our work is to use muscle stem cells to repair muscle tissue that has sustained major traumatic injury, a clinical challenge faced by a large number of Veterans and often referred to as “Volumetric Muscle Loss” (VML). Muscle stem cells are most effective in repairing muscle when they are in their native state, namely deeply embedded in muscle tissue. Therefore, we will attempt to enhance the current technology of using muscle stem cells to reconstruct VML lesions. Our main approaches will be to transplant muscle stem cells along with other supporting cells that may be critical to tissue generation. We will also test how exercise enhances the ability of muscle stem cells to generate new muscle. Finally, we are developing ways that will allow us to scale our treatment from experimental animals to humans. Our long-term goal is to be able to repair entire regions of damaged human muscle by transplanting human stem cells to contribute to the repair of muscle fibers, the regeneration of muscle tissue, and the restoration of muscle function.